The Cellular Geography of Therapeutic Resistance in Cancer

Abstract
No changes to abstract from parent award. Please see Research Strategy.

Public health relevance
Project Narrative No changes to Project Narrative from the parent award.